Mechanisms and specificity of sodium channel trafficking: Developing a novel analgesic strategy

Project Summary:
Mechanisms and specificity of sodium channel trafficking: Developing a novel analgesic strategy.
The burden of pain is significant and current pain treatments are often ineffective and addictive.
Alternatives are urgently needed. Voltage-gated sodium channel NaV1.7 is preferentially expressed in pain-
sensing neurons. Mutations in NaV1.7 can cause disorders ranging from intense pain (gain-of-function) to
complete painlessness (loss-of-function) in humans, suggesting that its inhibition could provide analgesia without
CNS side-effects or addictive potential. However, ongoing efforts to develop inhibitors of NaV1.7 conductance at
the cell membrane have not yet resulted in new therapies. We propose an alternative strategy for inhibition of
NaV1.7 function; reducing the number of channels at the cell surface by modulating their trafficking to and from
the cell membrane. Achieving this goal would require identifying and modulating mechanisms that specifically
mediate NaV1.7 trafficking. This project will investigate whether NaV1.7 is trafficked by specific mechanisms.
Whether NaVs are trafficked by dedicated mechanisms or together with other axonal proteins with
different functions is a fundamental question. NaV1.7 and NaV1.8 are functionally related, as they both
contribute to neuronal depolarization and promote pain. In contrast, voltage-gated potassium (KV) channels
oppose neuronal excitation and suppress pain. This proposal will test the hypothesis that ion channels with
different physiological functions are trafficked separately from each other according to their functions.
Previous attempts to observe sodium channel trafficking using fluorescent protein tags have failed
because the substantial pool of sodium channels in the cytoplasm and at the cell membrane conceal the weak
signal of individual vesicles carrying few channels. To overcome this, we developed Optical Pulse-chase
Axonal Long-distance (OPAL) imaging, which utilizes functional human NaV channels tagged with self-labeling
proteins (HaloTag and SNAPTag) and microfluidic chambers to selectively label channels that are being
actively trafficked in axons. This method allows live visualization of sodium channel vesicular sorting, axonal
transport, and endocytosis in distal sensory axons for the first time.
In the proposed experiments, we will examine two major aspects of axonal trafficking in turn: Aim 1 will
investigate anterograde trafficking to distal terminals and Aim 2 will interrogate endocytosis and retrograde
trafficking. In each Aim, we will 1) Determine whether NaVs are sorted into specific vesicles by live co-
localization imaging with tagged vesicle markers, 2) Determine whether different but functionally related NaV
isoforms are trafficked together, and 3) Determine whether functionally opposite NaV and KV channels are
trafficked together or separately. Together, these experiments will explain the logic of axonal vesicular
transport and potentially provide new therapeutic targets for pain.

Public health relevance
Project Narrative Pain is the leading cause of disability in the world and current treatments are ineffective and addictive. In this study, we examine the mechanisms by which ion channels necessary for pain are trafficked in pain-sensing neurons and whether types of ion channels with different physiological functions are trafficked together or separately. This study may lead to discoveries enabling the targeting of ion channel trafficking as a novel mechanistic strategy for pain therapy.